International TB Portals Program (that includes Belarus TB Portal project, Romania TB Portal project, Moldova TB Portal project, and Azerbaijan TB Portal project)

The International TB Portals Program has been successfully established as one of leading scientific resources of annotated high resolution X-ray and Computer Tomography lung images of tuberculosis patients. Additionally, ~500 mycobacterium tuberculosis DNAs have been collected for full genome sequencing, and are in various stages of processing at the NIAID DMID-supported Genome sequencing center (Broad Institute).